Acquisition of a Crystal Gryphon-LCP Crystallization Robot

ABSTRACT
In response to NOT-GM-22-017, Notice of Availability of Administrative Supplements for Equipment Purchases
for NIGMS Awardees, we request the funds to purchase the Crystal Gryphon-LCP Crystallization Robot. Our
parent grant aims to establish the structural bases regulating the key steps of protein synthesis: initiation,
termination, and ribosome recycling. While several crystal structures of the ribosome in complex with inhibitors
have been reported, the mechanisms that underline inhibition of translation factors off the ribosome remain
poorly understood. To enable structure determination and speed up as well as decrease the cost of crystallizing
our targets, we need a high-throughput crystallization system that can efficiently identify successful crystallization
conditions. The requested system offers sufficient high throughput to support not only the Gagnon lab, but also
the other x-ray crystallography labs within the Sealy Center for Structural Biology (SCSB), requires minimal
sample material, reliably uses either commercial crystallization screening kits (96-well SBS format) or specially
created screens, performs optimization using 96-well, 24-well, sitting-drop, or hanging-drop techniques, and
adds the capability of microseeding, which is proving essential to our project. In recognition of the broad benefit
of this instrument to the structural biology community within UTMB, the SCSB is committing space, long-term
maintenance, and staff for operation and user training of the instrument.

Public health relevance
PUBLIC HEALTH RELEVANCE Our parent grant aims to establish the structural bases regulating the key steps of protein synthesis: initiation, termination, and ribosome recycling. This supplement requests funding to acquire a high-throughput crystallization robot in order to accelerate the structural studies outlined in the parent grant.